Role of estrogen formulation and route of delivery on skeletal outcomes in functional hypothalamic amenorrhea

PROJECT SUMMARY/ABSTRACT
Low bone mass and fractures are a major complication of functional hypothalamic amenorrhea (FHA) in
adolescents and young adult women, including those with anorexia nervosa (AN) and exercise-induced
amenorrhea (EIA). Despite weight regain and menses recovery, bone mineral density (BMD) remains lower than
in normal-weight controls, likely because weight recovery is often partial, relapses are common, and not all
hormonal alterations contributing to low BMD completely normalize. Thus, additional intervention is necessary
to optimize skeletal health. A key contributor to impaired bone health is hypoestrogenism. Yet, estrogen
administration as the combined oral contraceptive (COC) pill (containing ethinyl estradiol (EE) and a progestin)
is not effective in improving skeletal health because of hepatic first pass effects resulting in a reduction in IGF-1
(a key bone trophic hormone, particularly during the adolescent years of peak bone accrual), and an increase in
SHBG (with a reduction in bioavailable estrogen). In contrast, transdermal physiologic 17β-estradiol (17β-E2)
(with cyclic progesterone), which bypasses hepatic first pass metabolism and does not decrease IGF-1 or
increase SHBG, increases bone accrual in both AN and EIA. However, transdermal 17β-E2 with cyclic
progesterone does not have contraceptive efficacy, leading to reduced uptake. The transdermal contraceptive
patch containing a non-physiologic form of estrogen (EE) with a progestin (levonorgestrel, LNG) offers a systemic
route of estrogen administration with avoidance of hepatic first pass metabolism. However, limited available data
suggest an increase in SHBG with EE, despite transdermal administration. Further, many women prefer an oral
pill because of skin irritation with the patch, cosmetic issues, and difficulty remembering to change the patch
once or twice a week vs. taking a pill daily. While COC pills containing EE are not effective in improving bone
outcomes, it is not clear whether oral 17β-E2 (a physiologic form of estrogen) could be as effective as
transdermal 17β-E2 despite hepatic first pass metabolism. Importantly, oral and transdermal 17β-E2 are often
used interchangeably in other hypogonadal states, despite evidence that oral 17β-E2 suppresses IGF-1 and
increases SHBG. We propose a randomized controlled trial of 2 mg oral 17β-E2 (with cyclic progesterone) vs.
100 mcg transdermal 17β-E2 (with cyclic progesterone) vs. 30 mcg transdermal EE (with levonorgestrel) in
young women 14-25 years old with FHA to determine whether transdermal 17β-E2 is more effective than oral
17β-E2 or transdermal EE in improving bone outcomes, or whether one or both of the latter two modes of
estrogen administration are equivalent to transdermal 17β-E2 in this context. We hypothesize that transdermal
17β-E2 will be superior to oral 17β-E2 and transdermal EE in achieving optimal improvement in bone geometry,
structure, density and strength (Aim 1), because of reductions in IGF-1 with oral 17β-E2 and increases in SHBG
with oral 17β-E2 and transdermal EE (Aim 2). Results could be paradigm shifting in the clinical management of
young women with FHA and potentially allow for alternative forms of estrogen administration in those with FHA.

Public health relevance
PROJECT NARRATIVE Low bone density and an increase in fracture risk are important complications of anorexia nervosa and exercise induced amenorrhea in adolescents and young adult women. An important cause of low bone density in these young women is low levels of estrogen. We will assess the impact of different routes and formulations of estrogen on bone outcomes in these young women.